Lightsheet Microscope

Project Summary/Abstract:
Three-dimensional imaging of large samples is becoming a vital technology for identifying
complex cell migration patterns, vascular integrity, developmental cell patterning and neural
circuit complexity, all essential components of research at Lewis Katz School of Medicine at
Temple (LKSOM). To support these research efforts, this shared instrument application
requests funds for a lightsheet microscope. This lightsheet microscope will be an important
addition to the Imaging Core supported over the past 10 years by grant funding through
Shriners Hospitals for Pediatric Research. The mission of the imaging core is to provide a full
range of state-of-the-art imaging equipment, training, and technology at a cost-effective rate.
The imaging core presently has a 2 confocal, 1 multi-photon, TIRF, stereological system, laser
capture, and 3 wide-field epifluorescent scopes, with over 20 researchers at Shriners Research
Center, LKSOM, and Temple University who have acknowledged this core in their publications
and in over 45 federal or private foundation grants.
The lightsheet microscope is an important and necessary addition to the imaging core by
supporting high resolution 3D imaging not capable by our present imaging devices. It will have
a fundamental and significant impact on currently PHS funded projects as well as biomedical
discoveries disseminated through high impact publications. The need for a lightsheet
microscope developed through interactions and collaboration with multiple investigators for the
need of this technology to significantly enhance their current and future research efforts.
Additionally, this shared instrument will also enhance our ability to recruit new faculty who have
a critical need for 3D imaging for their research program. As with all high-end imaging
instrumentation, individual labs have insufficient funds to purchase or maintain a lightsheet
microscope. Therefore, it is highly relevant instrument to be shared by multiple investigators
and supported by an established imaging core with 10 years of experience and funding,
qualified to operate, manage and maintain this microscope.

Public health relevance
Project Narrative: This proposal requests support for a lightsheet microscope in response of the needs of the researchers whose studies require high resolution 3D and 4D imaging of cleared tissue or to examine cellular patterns of migration or structure within complex tissues. This instrument is required to fill a critical imaging gap that would be highly beneficial to the researchers at Temple University. Our present imaging core has the infrastructure and demonstrated over 10 years of successfully managing, operating, and maintaining high-end imaging microscopes.